Interactions between the chronic sequelae of stroke and Alzheimer's disease

PROJECT SUMMARY
Evidence in humans suggests that vascular risk factors, such as stroke, increase the risk of, or in some cases
have a synergistic effect on, the development of Alzheimer's disease (AD). Most vascular dementia (VaD) and
AD mixed dementia patients exhibit more varied pathology with respect to β-amyloid (Aβ) accumulation, brain
atrophy, and neurodegeneration than typical “pure” AD patients. At present, the precise number of patients
presently diagnosed with a particular type of dementia that actually have mixed dementia is not known; however,
post-mortem analyses suggest that the condition may be present in over half of patients clinically diagnosed with
AD. Furthermore, despite the frequent co-existence of VaD and AD, little is known about how these diseases
influence each other, in part due to the lack of adequate animal models.
In light of this gap, the objective of Aim 1 of this proposal is to further develop two innovative new models of
mixed dementia that can be used to investigate how the long-lasting pathological sequelae of ischemic stroke
impact the AD phenotype. To that end, our preliminary data show in a mixed dementia model using aged wildtype
(wt) mice, impaired motor recovery and accelerated onset of cognitive impairment in aged C57BL/6 mice
compared to young adult mice in the months following ischemic stroke. This behavioral manifestation
corresponds with increased brain atrophy and cholinergic degeneration as well as a focal increase in Aβ and tau
pathology in areas of axonal degeneration and white matter tracts of the ipsilateral hemisphere. In contrast, our
preliminary data show that in a mixed dementia model using aged transgenic Aβ precursor protein transgenic
mice (AβPPL/S), that ischemia exacerbates behavioral deficits and that this correlates with a global increase in
Aβ and tau pathology compared to AβPPL/S mice that undergo a sham procedure. Furthermore, in both models,
the stroke-induced AD pathology co-localized with the presence of, or increases in, β-secretase (BACE) 1 and
neuregulin (NRG) 1 type III, both of which are necessary for myelin repair.
Therefore, we hypothesize that the chronic sequelae of stroke, for example, axonal degeneration,
inflammation, blood brain barrier dysfunction, and impaired paravascular clearance, initiate a myelin repair
pathway that leads to the abnormal genesis of AD-like pathology in aged wt mice, and exacerbates pathology in
aged AβPPL/S mice. Consequently, after we have further developed these two mouse models, we will use them
to determine if the BACE1-dependent myelin repair pathway is necessary for stroke recovery, but
antagonistically also leads to the generation of AD-associated pathology. Finally, we will determine if the small
molecule p75 neurotrophin receptor (p75NTR) ligand, LM11A-31, which is currently in Phase 2a clinical trials for
the treatment of AD, and which preserves myelinated axons following spinal cord injury, slows or prevents the
development of mixed dementia-related behavioral and pathological abnormalities in mice that have undergone
a stroke.

Public health relevance
PROJECT NARRATIVE Vascular dementia resulting from cerebrovascular pathology is the second most prevalent type of dementia after Alzheimer's disease (AD), both of which are more likely to develop with advancing age. Mixed dementia is the co-existence of cerebrovascular and AD-associated neuropathology and poses increasing personal, societal, and economic burdens. The goal of this research is to develop two new mouse models of mixed dementia to define the role of a β-secretase (BACE) 1-dependent myelin repair pathway in driving AD mixed dementia pathology after stroke, and to test a Phase 2a therapeutic compound that targets fundamental mechanisms relevant to AD pathogenesis in post-stroke mixed dementia using the mouse models.